RESPONSE TO CANCER-RELATED INQUIRIES

The purpose of this contract is to assist the Office of Cancer Communications, National Cancer Institute, in providing technical writing, publication distribution, and telephone answering services in response to cancer-related inquiries.